CHARACTERIZATION OF SMALL-MOLECULE DRUG CANDIDATES USING STANDARDI

CHARACTERIZATION OF ABSORPTION, DISTRIBUTION, METABOLISM, EXCRETION, AND TOXICITY (ADMET) PROPERTIES OF SMALL-MOLECULE DRUG CANDIDATES